Provision of Phlebotomine Sand Flies for Leishmania

This IAA will support the maintenance of three sand fly colonies (2 strains of Phlebotomus papatasi and 1 strain of Lutzomyia longipalpis) to support Leishmaniasis researchers. These resources will be available through the NIAID BEI repository website.